Investigating the impact of preference-concordant differentiated service delivery for HIV

Background. Differentiated service delivery (DSD) for HIV care, an approach to better serve clinical and social
needs among people living with HIV (PLWH), has been adopted to improve adherence and retention in care.
The current DSD programs include four different categories (within-facility individual, out-of-facility individual,
provider-managed group, client-managed group). Studies have so far shown mixed results of DSD relative to
conventional ART delivery. In 2021, the World Health Organization revised its guideline to expand DSD to offer
more individualized HIV services to all PLWH. Currently, DSD individualization is often based on clinical
stability or availability of human resources, rather than patient preferences and needs. As countries expand
DSD, preference-based individualization of DSD could improve health outcomes and quality of life. This K01
provides a unique opportunity to address these research gaps.
Candidate Overview. My long-term career objective is to become an independent investigator who specializes
in incorporating patient-centeredness into health programs for PLWH in low- and middle-income countries.
While I have developed research skills in epidemiology, statistical methods, discrete choice experiments and
preference assessment, this K01 award will provide the necessary additional training and experience to be an
independent investigator in the design and evaluation of patient-centered health programs to improve clinical
outcomes and quality of life among PLWH and inform policy decision-making.
Career Development and Training Plan. My educational program includes structured coursework,
professional conferences, directed readings, and a research project with specific aims timed to coincide with
these activities. My mentorship team includes international experts who specialize in areas related to my
training goals: Dr. Scott Braithwaite (decision science and comparative effectiveness), Dr. Anna Bershteyn
(agent-based mathematical modeling), Dr Carolyn Berry (qualitative research), Dr. Elvin Geng (implementation
science), and Dr. Elizabeth Bukusi (study execution and dissemination in Kenya).
Environment. NYU School of Medicine provides an exceptional environment to conduct the proposed study,
obtain additional training and mentorship, and successfully transition to an independent investigator.
Research Strategy. My study will evaluate the impact of preference-concordant programs on patient and
population outcomes using a prospective cohort study and mathematical modeling in western Kenya.
Specifically, the study will: 1) measure the trade-offs that patients are willing to make among different features
of DSD programs and how these preferences vary by patient characteristics; 2) determine how preference-
concordant DSD programs impact retention, adherence, and viral load suppression; 3) estimate the long-term
health impact and costs of preference-concordant DSD programs using mathematical modeling.

Public health relevance
The proposed research aims to understand patient preferences for differentiated service delivery (DSD) programs among people living with HIV and examine the impact of preference-concordant DSD programs on clinical outcomes, quality of life, and progress toward controlling the HIV epidemic in Kenya. The results of this work will inform the design of more patient-centered DSD programs and policy decision-making in Kenya and other high HIV burden settings.